Identifying the magnitude and impact of pelvic floor disorders in Veterans with lower limb amputation

Pelvic floor disorders (PFDs) is the broad term used to describe a number of impairments that affect millions of
women and men in the U.S. Symptoms of PFDs resulting from over- or underactivity of pelvic musculature
manifest in a variety of ways, including urinary and fecal incontinence, urinary frequency or urgency, as well
sexual dysfunction and pelvic pain syndromes. Pelvic floor disorders are poorly understood in people with
physical disabilities, and Veterans with lower limb amputation (LLA) are one such group of individuals. Pelvic
floor disorders are effectively managed with conservative, non-pharmacological treatment, but left undiagnosed
can adversely affect many facets of functioning and well-being. People with LLA frequently exhibit conditions
associated with PFDs in the non-LLA population, including low back pain and heightened fall risk, yet the
presence of PFDs have not been systematically assessed in individuals with LLA. With over a million people
living with LLA in the U.S., this may pose a significant health burden that is currently not being addressed. The
overall objective of this proposal is to better understand the magnitude and impact of PFDs on health-related
quality of life in Veterans with LLA. We will explore the prevalence of PFDs amongst men and women with LLA
and the physical and behavioral sequalae associated with the presence of symptoms of PFDs. We propose to
comprehensively address the gaps in knowledge by administering surveys, including psychometrically sound
outcome measures, to assess symptoms of PFDs, to 200 study participants of both sexes (n ≥ 100 females). All
surveys will be remotely administered to participants, to optimize convenience and study enrollment. Our
proposed study has three aims:
Specific Aim 1: To estimate the prevalence of PFDs in a cohort of male and female Veterans with LLA.
This descriptive aim will provide seminal data on the magnitude of PFDs in Veterans with LLA and can serve as
a proxy estimate for rates in the LLA population in general. Estimates will be provided based on sex and level of
LLA (trantibial, transfemoral, etc.) The primary measure of PFD symptoms will be the Pelvic Floor Distress
Inventory (PFDI-20), with secondary measures administered to explore other aspects related to PFDs in men
and women. Furthermore, this aim will assess the feasibility of collecting self-reported pelvic/urogenital
information and the acceptability by Veterans to PFD-related survey items.
Specific Aim 2: To examine associations between PFDs and low back pain, and prosthetic mobility in
Veterans with LLA. This aim is designed to determine physical sequelae related to the presence of PFDs. We
expect that (2A) there will be significant relationships between PFDs and scores on the Oswestry Disability Index
as a measure of low back pain, and (2B) lower scores of prosthetic mobility, as measured by the Prosthetic Limb
Users Survey of Mobility™ will be associated with PFDs.
Specific Aim 3: To examine the extent to which PFDs contribute to fall risk and levels of activity
participation in Veterans with LLA. This aim will examine the impact of reported PFDs relative to behavior
constructs affecting health-related quality of life. We anticipate that (3A) there will be significant levels of
association between PFDs with reported fall occurrence, and that (3B) the presence of PFDs will be associated
with decreased activity participation, both social and work related.
Impact. Successful completion of this work will establish an evidence base regarding PFDs in male and female
Veterans with LLA. This SPiRE presents an opportunity to shift the paradigm of LLA rehabilitation by elevating
the consideration of often-ignored variables that could be contributing to increased rates of falls, low back pain,
and poorer quality of life in this population.

Public health relevance
Pelvic floor disorders (PFDs) is the broad term used to describe a number of conditions that affect millions of women and men in the U.S. Pelvic floor disorders resulting from over- or underactivity of pelvic muscles result in a variety of symptoms, including urinary and fecal incontinence, urinary frequency or urgency, as well sexual problems and pelvic pain syndromes. Despite the common occurrence of PFDs, there is no research examining if PFDs are a problem for men and women with lower limb amputation (LLA). Common impairments of low back pain (LBP), falls, and mobility deficits in people with LLA could be associated with coexisting undiagnosed PFDs. The overall purpose of this research is to better understand the extent at which PFDs occur in Veterans with LLA and any impact on lifestyle and functioning with their prosthesis. The clinical significance of the study will be in establishing an evidence base of PFDs in people with LLA and providing a foundation for future research on the evaluation and treatment of PFDs in people with LLA. Project Narrative